Adjuvanted Intranasal influenza vaccine to generate lung resident-memory T cells

ABSTRACT
Influenza vaccine capable of providing broadly cross-reactive and heterosubtypic Immunity (HSI) is a
strategic solution to overcome the uncertainties associated with annual influenza immunizations. Lung
resident memory CD8 T cells are important players in heterosubtypic immunity and protection after influenza
infections. Current vaccine technologies used in influenza vaccines are not very effective in generating lung
resident T cell memory, with the exception of live attenuated influenza vaccines (LAIV). We have recently
demonstrated an enantiomer specific 1,2-dioleoyl-3-trimethylammonium-propane (R-DOTAP) as immune
stimulatory cationic lipid (CL), which can adjuvant intramuscularly administered recombinant proteins to
generate robust cellular and antibody mediated response. In preliminary studies, we observed this CL can
also induce potent immune responses when administered intranasally. In this proposal, we will characterize
T cell-mediated immune responses to R-DOTAP adjuvanted influenza vaccines delivered as an intranasal
formulation with emphasis on its ability to generate tissue-resident memory CD8 T cells and provide
protective and cross-reactive CD8 T cell immunity to an infection challenge. In the first specific aim we will
evaluate lung-resident memory T cell induction by intranasal R-DOAP adjuvanted recombinant protein
vaccine. In the second specific aim, we will evaluate the vaccines efficacy to protect mice from a
heterosubtypic Influenza A challenge. A thorough characterization of R-DOTAP’s ability to induce lung
resident T cells will be useful for the adjuvant development field and contribute to the development of effective
next-generation vaccines.

Public health relevance
Project Narrative This project will we will develop and test an intranasal influenza vaccine using R-DOTAP nanoparticles and recombinant influenza proteins. We will assess the vaccine ability to generate vaccine specific T cell immunity in the lungs, which is essential for protection. Information obtained through this research will directly benefit public health through the development of a safe and effective vaccine against influenza.